Centers of Excellence for Influenza Research and Surveillance

This interagency agreement is part of NIAID's Centers of Excellence for Influenza Research and Surveillance program. The objective of this research project is to characterize low pathogenic animal influenza A viruses in swine.